Inflammasomes - a driver of sexual dimorphism to glioma therapies

ABSTRACT
Malignant gliomas remain lethal with available therapies, including immune checkpoint blockade. Tumor cells
and glioma-associated microglia/macrophages (GAMMs) collectively activate inflammatory responses in the
tumor microenvironment (TME), leading to immune suppression, therapy resistance, tumor progression, and
relapse. Hence, targeting the protumorigenic TME inflammation is an attractive approach against gliomas. TME
inflammation can be induced by inflammasomes, cytosolic innate immune protein complexes that induce
cytokine secretion. The NLRP3 inflammasome is expressed in multiple immune cells, and we have identified a
population of NLRP3+IL- + proinflammatory macrophages in gliomas. Intriguingly, we found that (1) NLRP3+IL-
+ GAMMs are increased in both normal and glioma-bearing females, (2) NLRP3-responsive inflammatory
genes are enriched in the mesenchymal glioblastoma subtype, (3) high NLRP3 levels are associated with a poor
prognosis in female mesenchymal glioblastoma patients, and (4) inflammasome and inflammatory proteins are
higher in gliomas from female mice. Our data is consistent with the known inflammatory propensity of females
and the presence of key immune regulatory genes on the X chromosome. To determine whether NLRP3
inhibition would overcome inflammation-induced immune suppression and potentiate antitumor immune
therapies, we treated male and female glioma-bearing mice with an EGFR targeting antibody toxin conjugate
(ATC) and either pharmacological inhibition or genetic deletion of NLRP3. ATC + NLRP3 inhibition/deletion
significantly prolonged survival in female but not male mice. In addition, estrogen receptor signaling inhibition
decreased NLRP3 and Caspase-1 levels in gliomas during ATC or radiation therapy, indicating a role for sex
hormones in NLRP3 regulation. Hence, we hypothesize that NLRP3-induced inflammatory responses promote
immune suppression and dampen therapy-induced antitumor responses, specifically in females. Herein, we will
1) Determine whether NLRP3+IL- + GAMMs are primary regulators of sex-dependent ATC therapy response,
2) Determine whether sex hormones vs. sex chromosomes regulate NLRP3 and sex-dependent ATC antitumor
response, and 3) Determine whether NLRP3 signaling regulates antitumor responses to radiotherapy in a sex-
dependent manner.
1

Public health relevance
PROJECT NARRATIVE Glioblastoma (GBM) is the most common and aggressive type of brain cancer in adults, and despite attempts to improve outcomes, effective treatment for GBM remains an unmet need, making evaluation of novel therapeutic approaches that will benefit individuals afflicted with this debilitating disease critical. To improve GBM patient survival, we propose targeting abnormal inflammation induced by tumor and immune cells in the tumor microenvironment while simultaneously destroying tumor cells in a sex-specific manner. This study will provide mechanistic insights into a novel combination therapy that potentially improves sex-specific GBM patient survival.